West Virginia Clinical and Translational Science Institute: A Statewide Organization Building Research Excellence and Engaging Communities to Improve Health

West Virginia (WV), the only state located entirely in Appalachia, has the lowest life expectancy in the
nation and ranks at or near the bottom in many chronic disease categories. The WV Clinical and
Translational Science Institute (WVCTSI) was created in 2012 through the initial Institutional
Development Award for Clinical and Translational Research (IDeA-CTR) and successfully renewed in
2017. Over the past 9 years, WVCTSI has cultivated and nurtured a highly collaborative, statewide
research infrastructure to address the substantial health disparities in WV. Over the past 4 years,
WVCTSI productivity has been superb with 1,325 publications, 951 funding applications, and 688
external funding awards totaling $159.3 MM. The WVCTSI’s overarching goal for the next funding
cycle is to serve as a transformational force, leading statewide clinical and translational collaborative
research that positively impacts health outcomes in WV. We will achieve this goal through the following
specific aims: Specific Aim 1 - Build collaborative, productive research infrastructure across WV that
substantively contributes to improving WV health outcomes, Specific Aim 2 - Train and position for
success the next generation of clinical and translational scientists, and Specific Aim 3 - Actively engage
multiple stakeholders, including rural communities, in research and effectively disseminate research
results to rural populations in a manner that facilitates understanding and trust. There are 3 important
cross-cutting themes around which our efforts will be focused that include: 1) Rural Health, 2) Diversity,
Equity, and Inclusion (engaging not only WV’s rural communities but also WV’s communities of color;
equally important is supporting diverse investigators), and 3) the clinician scientists of tomorrow – able
to frame the right questions and work to find the answers. Central to attainment of our specific aims
is the highly collaborative statewide organization that WVCTSI has developed over the preceding 9
years and that now includes every major healthcare organization and academic medical center in WV,
the state health department (WVDHHR), the National Institute for Occupational Safety and Health, and
>100 primary care organizations across WV that constitute the WV Practice-Based Research Network.
Equally important is the high level of collaboration and commitment among WVCTSI’s cores.
Successful completion of our objectives will inform policy, practice, and community changes resulting
in improved WV health outcomes.

Public health relevance
West Virginia has the lowest life expectancy in the nation and ranks at or near the bottom in many chronic disease categories. The overarching goal of the West Virginia Clinical and Translational Science Institute is to grow research that accelerates delivery of solutions to health disparities in West Virginia.